Etiology and pathogenesis of lethal lung developmental disorders in neonates

Project Summary
Lethal lung developmental disorders (LLDDs) are rarely diagnosed but devastating pulmonary hypoplasias
(PHs), presenting with progressive neonatal hypoxia and severe pulmonary arterial hypertension (PAH). Based
on histopathological appearance, LLDDs have been traditionally classified as alveolar capillary dysplasia with
misalignment of pulmonary veins (ACDMPV), acinar dysplasia (AcDys), congenital alveolar dysplasia (CAD),
and other unspecified primary PHs. We found that heterozygous single nucleotide variants (SNVs) in the
mesenchymal transcription factor (TF) FOXF1 gene or copy-number variant (CNV) deletions involving FOXF1
or its lung-specific enhancer located ~ 300 kb upstream are responsible for ACDMPV in 80-90% of patients. We
reported that this enhancer also up-regulates in cis lncRNA FENDRR mapping nearby FOXF1. Interestingly,
unlike SNVs, CNV deletions arise almost exclusively on the maternal chromosome 16. Recently, we and others
demonstrated the causative role for variants in another mesenchymal TF, TBX4, and a paracrine signaling
molecule FGF10 in greater than 60% of infants with AcDys, CAD, and other primary PHs, indicating the
significance also of TBX4-FGF10 signaling in pathogenesis of LLDDs. Importantly, FOXF1 and TBX4 variants
have been associated also with more common idiopathic or familial childhood PAH. Interestingly, we found a
statistically significant enrichment of non-coding SNVs in the FOXF1 and TBX4 enhancers in patients with
variable presentation of LLDD. Moreover, our ChIP-seq and RNA-seq studies have implied interactions between
the SHH-FOXF1 and TBX4-FGF10 signaling pathways, involving little-known lung-specific endothelial
transmembrane protein TMEM100. We hypothesize that (i) non-coding SNVs within the regulatory regions of
lung developmental genes can dramatically modify (alleviate or exacerbate) LLDD and PAH phenotypes, (ii) an
interplay between the coding and non-coding variants can explain the complex compound inheritance observed
in families with LLDDs and PAH, and (iii) interaction of SHH-FOXF1 and TBX4-FGF10 signaling pathways,
involving TMEM100, is required for proper human lung development. Using human lung specimens and cell lines
and mouse models, we will identify and analyze non-coding regulatory elements of FOXF1 in patients with
ACDMPV and/or PAH (Aim 1) and those of TBX4 and FGF10 in patients with AcDys, CAD, other PHs, and/or
PAH (Aim 2). In Aim 3, we will decipher the crosstalk between SHH-FOXF1 and TBX4-FGF10 epithelial-
mesenchymal signaling, involving TMEM100, to untangle the complex compound inheritance in families with
LLDDs and PAH. Our studies will elucidate the genetics of lung development in humans and how its perturbations
translate to phenotypic variability of LLDDs and PAH. We will identify new genetic variants, allowing for more
precise diagnosis and prognosis of these disorders, facilitating more informative genetic counseling, and
providing targets for development of potential in utero treatments for LLDDs and PAH. Our data will also help to
better understand incomplete penetrance and variable expressivity phenomena in human genetics in general.

Public health relevance
PROJECT NARRATIVE The main focus of our research is studying the role of SHH-FOXF1 and TBX4-FGF10 signaling pathways in epithelial-mesenchyme interactions during human lung development as well as in etiology of lethal lung developmental disorders (LLDD) and pulmonary arterial hypertension (PAH) in neonates. In particular, we are interested in an interplay between the pathogenic coding variants and the regulatory non-coding regulatory elements of the FOXF1, FENDRR, TBX4, and FGF10 genes, implied in complex compound inheritance of these disorders. We hypothesize that (i) non-coding variants are promising therapeutic target and (ii) that a little known transmembrane protein TMEM100 mediates SHH-FOXF1 and TBX4-FGF10 signaling during human lung development.